TR&D 1: Reimagining the Future of Scanning: Intelligent image acquisition, reconstruction, and analysis

TRD1 Project Summary
The broad mission of our Center for Advanced Imaging Innovation and Research (CAI2R) is to bring
together collaborative translational research teams for the development of high-impact biomedical imaging
technologies, with the ultimate goal of changing day-to-day clinical practice. Technology Research and
Development (TR&D) Project 1 aims to replace traditional complex and inefficient imaging protocols with
simple, comprehensive acquisitions that also yield quantitative parameters sensitive to specific disease
processes. In the first funding period of this P41 Center, our project team led the way in establishing rapid,
continuous, comprehensive imaging methods, which are now available on a growing number of commercial
magnetic resonance imaging (MRI) scanners worldwide. This foundation will allow us, in the proposed
research plan for the next period, to enrich our data streams, to advance the extraction of actionable
information from those data streams, and to feed the resulting information back into the design of our
acquisition software and hardware. Thanks to developments during our first funding period, we are now in a
position to question long-established assumptions about scanner design, originating from the classical imaging
pipeline of human radiologists interpreting multiple series of qualitative images. We will reimagine the process
of MR scanning, leveraging our core expertise in pulse-sequence design, parallel imaging, compressed
sensing, model-based image reconstruction and machine learning. We will also extend our methods to
complex multifaceted data streams, arising not only from MRI but also from Positron Emission Tomography
(PET) and other imaging modalities, as well as from diverse arrays of complementary sensors.